GENETIC ANALYSIS OF DENGUE VIRUS ENVELOPE GLYCOPROTEIN AND ITS IMMUNOGENECITY

The antigenic structure of dengue envelope (E) glycoprotein was investigated with the goal of increasing its immunogenicity. Recombinant vaccinia viruses were constructed that contained dengue cDNA coding for C-terminally truncated E that ranged in length from 9% to 99% of the N-terminal sequence. Overall antigenicity of the E products was analyzed by radio-immunoprecipitation using dengue hyperimmune mouse ascitic fluid HMAF) or an E peptide antiserum. With the exception of 59%E, only E constructs greater than 79% were able to bind HMAF efficiently. Arg at position 392 in the dengue type 4 E sequence immediately following the 79%E C-terminus appeared to be critical for proper conformation and antigenic structure required for efficient binding by HMAF. Full-length E was retained intracellularly, and only truncated E ranging from 59% to 81% in length was secreted extracellularly. Only 79%E-RKG (that possessed the 3 additional amino acids immediately downstream of 79%E) was expressed in high concentration on the surface of recombinant virus-infected cells presumably being inserted into the plasma membrane by a C-terminal membrane anchor that included a 20 amino acid hydrophobic transmembrane domain and a short charged amino acid cytoplasmic domain. Studies in mice indicated that only truncated E's that were recognized efficiently by HMAF induced a high level of resistance to dengue virus encephalitis. Among the truncated E's that were able to bind HMAF efficiently only 79%E-RKG was expressed in high concentration on the cell surface. Significantly, only 79%E-RKG induced an appreciable E antibody response suggesting that cell surface expression was responsible for its enhanced immunogenicity. Finally, passive immunization studies in mice involving serum transfer indicated that serum antibodies to E played a major role in the complete or nearly complete resistance to dengue virus challenge induced by certain vaccinia virus-truncated E recombinants.